Exploring the Conformational Landscape of G Protein Coupled Receptors

Project Summary G protein coupled receptors (GPCRs) are important transmembrane signaling proteins, which
are activated by a multitude of extracellular ligands ranging from small molecules to entire proteins. Active
GPCRs couple to different intracellular transducer proteins, such as G proteins and arrestins, thereby triggering
diverse cellular responses. Due to their fundamental involvement in a multitude of signal transduction processes,
many diseases have their origin in a malfunctioning GPCR, and approximately 35% of all FDA-approved drugs
directly target a GPCR. Receptor promiscuity towards ligands and transducer proteins entails that drugs
designed to alleviate symptoms are often associated with a range of possible side effects. A detailed molecular
understanding of ligand binding, receptor activation and signal transfer is thus pivotal in order to facilitate design
of receptor-specific and highly efficacious drugs with enhanced selectivity for downstream signaling pathways.
To fulfil their role as allosteric and highly promiscuous regulatory proteins, GPCRs rely on a high degree of
structural flexibility, which allows large scale conformational changes thus facilitating specific recognition by
binding partners of distinct shape and size. An important and currently unexplored question is to what extent the
motions of individual receptor segments are coupled, as opposed to moving independently. This new paradigm
suggests that therapeutic drugs could be designed that modulate only a selected subset of conformational
changes, while leaving other parts of the receptor unaffected. Identifying networks of coupled segments will
define new targets for drug research and facilitate design of functionally selective therapeutics with fewer side
effects. We will be testing this hypothesis investigating two prototypical GPCRs of very different function – the
light receptor rhodopsin (Rho) and the peptide-activated type 1 angiotensin II receptor (AT1R) - using newly
developed site-directed spin labeling and electron paramagnetic resonance (EPR) spectroscopic techniques. In
Aim (I) we will determine the number and topology of different receptor conformations. For this purpose we will
shift the conformational equilibria using a variety of different ligands and the application of hydrostatic pressure
to map the conformational landscape of both GPCRs using Double Electron-Electron Resonance (DEER)
spectroscopy. In Aim (II) we will develop an improved time-resolved EPR method (“TRED”) to determine
activation energies and coupling between segmental motions. TRED will be capable of resolving conformational
changes with microsecond time resolution and Angstrom spatial sensitivity. In Aim (III) we will determine
segmental coupling during Rho and AT1R activation, triggered by flash illumination and pressure jump,
respectively. Comparison of the two receptors will allow us to identify coupling networks and transition states of
activation, which are either conserved among GPCRs or receptor-specific, thus suggesting target sites for drug
design. Accomplishing the aims of this proposal will reveal a new dimension of molecular pharmacology, which
has the potential to improve the lives of millions suffering from acute or chronic disease.

Public health relevance
PROJECT NARRATIVE The central objective of the proposed project is to investigate a largely unexplored but crucial aspect of G protein coupled receptor activation, namely the extent of coupling of different receptor segments. Identification of coupling networks will be made using novel electron paramagnetic resonance spectroscopy methods that resolve segmental motions in both space and time. The characterization of coupling networks will have broad implications for molecular pharmacology.